The Role of lymphatic endothelium in the developing thymus

PROJECT SUMMARY/ABSTRACT
Studies of the thymic microenvironment have focused largely on the central role of thymic epithelial cells (TECs)
during development, disease and aging. However recent evidence suggests that the thymic vascular
compartment also plays an active and complex role within the thymus beyond that of a simple conduit for
hematopoietic cells. This role is particularly evident during the neonatal period when robust thymopoiesis is
accompanied by a profound though transient phase of angiogenesis, followed by rapid maturation of TECs. This
research proposal builds on the recent and novel finding that the vasculature of the neonatal thymus is in fact
dominated by lymphatic endothelial cells (LECs) rather than blood endothelial cells (BECs), the latter becoming
dominant by early adulthood. The application of classical LEC-associated cell surface markers is problematic in
the thymus in which these markers are either undetectable or expressed on other cell types. The few reports
describing the existence of lymphatics in the thymus have studied the adult organ in which LECs are very rare.
As a result, the existence of the lymphatic compartment of the thymus has remained largely ignored and the
function of LECs and the vasculature they form is unknown. The recent development of key technical advances
now allows us to explore this poorly understood cellular compartment of the thymus. Reliable mouse models
developed to study LECs in other organs, will now be applied for the first time to identify and manipulate LECs
in the thymus. Single cell transcriptomics, including spatial gene expression and proteomics, will allow the
detailed simultaneous analysis of LECs, BECs and the other compartments of the thymus during development
and after in vivo perturbation of LECs. By combining these powerful technologies, we will test the hypothesis
that the lymphatic vasculature of the neonatal period plays a critical role in both the remodeling and maturation
of the murine thymic architecture and the differentiation and egress of T cells during the same period. The
transcriptional signature of thymic LECs so developed in the mouse will allow direct comparative transcriptional
studies of the LECs in the human thymus that would be impossible by standard assays. Specifically, we aim to:
1. Define the lymphatic compartment of the thymus during development at the cellular and transcriptional level
2. Determine if inhibition of lymphangiogenesis affects development of the thymic microenvironment
3. Define the role of lymphangiogenesis in T cell differentiation and egress from the developing thymus
In summary we will use the unique window of the murine neonatal period to define the factors that control the
growth and regression of the lymphatic endothelium in the thymus, as well as the role of LECs in the dramatic
concurrent changes seen in the other thymic compartments. The ultimate goal of these studies is to uncover
novel pathways that may be explored for enhancing thymic function and regeneration to improve immunity and
health.

Public health relevance
NARRATIVE The production of new T cells is controlled in an organ called the thymus. This project will study how the type of vasculature in the thymus contributes to the rapid growth of the organ that occurs in the newborn period. The ultimate goal of these studies is to uncover novel pathways to enhance T cell production in the thymus to improve health by reversing immune deficiencies associated with organ transplant, cancer treatment and aging.